Independent Assessment of the Translator Program

The Health FFRDC Operator shall perform an independent assessment and comparison of up to three Autonomous Relay Agents (ARAs). The scope of the assessment will be finalized in collaboration with the Health FFRDC and will comport with the available resources and time.